Role of Rasa1 in embryonic development

PROJECT SUMMARY
Vascular and lymphatic anomalies comprise a spectrum of defects that originate in embryonic blood
or lymphatic vessels and are present at birth. These defects can be congenital or sporadic and nearly
50 genes bearing causative mutations have been identified for both cases. Among these is RASA1,
which encodes a negative regulator of the RAS GTPase that is normally activated by growth factor
signaling. Germline autosomal dominant mutations in RASA1 lead to capillary malformation-
arteriovenous malformation (CM-AVM) syndrome, in which patients exhibit port wine stains on their
skin at birth. CM-AVM patients also harbor AVMs, which are direct artery/vein connections without an
intervening capillary bed, or lymphatic anomalies. AVMs usually occur in the brain where they have a
significant negative health impact, while the fast-flow nature of AVMs can lead to cardiac overload.
Lymphatic anomalies can perturb fluid clearance, leading to cardiac or pleural effusions, and hydrops
fetalis. Accordingly, AVMs and lymphatic anomalies can contribute to fetal demise or early neonatal
lethality and therapeutic options are limited. Mouse models have provided important insights into the
role of Rasa1 in embryogenesis, including its requirement for vascular and lymphatic development.
However, many defects in Rasa1-deficient mouse embryos are not seen in human CM-AVM lesions
and this model fails to mimic postnatal features of CM-AVM, underscoring the need for additional
animal models. We have developed rasa1-deficient zebrafish embryos and show that they exhibit
defects in both vascular and lymphatic development, including vascular regression defects not
previously noted in other models. Adult zebrafish carriers of mutant rasa1 alleles also show evidence
of presumptive capillary malformations, suggesting that they may exhibit hallmarks of CM-AVM. To
study the role of Rasa1 in zebrafish, we have developed numerous genetic tools, including zebrafish
bearing a floxed rasa1a allele and endothelial Cre driver lines. Using these tools, we will define the
cellular and molecular effects of rasa1 deficiency that give rise to lymphatic defects. In addition, we
will investigate how rasa1 acts to mediate vascular regression and whether defects in this process
contribute to AVM formation. Finally, we will characterize presumptive capillary malformations in
rasa1 carriers, while assessing this model as a platform for preclinical testing of therapeutic small
molecule candidates to alleviate CM-AVM defects. Together, our studies will provide valuable insight
on the embryonic role of Rasa1 in development and how its deficiency contributes to formation of
vascular and lymphatic anomalies.

Public health relevance
PROJECT NARRATIVE Inherited mutations in RASA1 cause vascular anomalies that appear at birth and can have major negative health impacts. The proposed studies will investigate the role of RASA1 during embryonic development and assess the zebrafish as a model to study associated vascular anomalies.